Determining the Role of csoS2 in Carboxysome Assembly and Regulation

PROJECT SUMMARY/ABSTRACT
Bacteria Microcompartments (BMCs) are pseudo-organelles comprised of a highly organized, semi-permeable
protein shell which self-assembles around components of specific metabolic pathways. BMCs offer bacteria an
advantage to survive in harsh conditions, to organize the cytosol by separating reactive components from each
other, or to increase efficiency of enzymatic pathways by tuning local concentrations. Genetic models suggest
that the compact organization of the BMC loci is ideally suited for lateral transfer to other bacteria, increasing the
potential for greater prevalence of this feature in the future. Understanding the mechanisms of BMC assembly,
organization, and stability are important to developing new approaches involving human-bacteria interactions
and symbiosis.
The model BMC is a key component in the CO2 concentrating mechanism (CCM) found in cyanobacteria called
the carboxysome (CB). CBs sequester Rubisco with carbonic anhydrase and CO2 increasing carbon fixing
efficiency. Rubisco is the most abundant enzyme on earth and the protein responsible for carbon fixation in
plants, bacteria, and algae. Rubisco has low selectivity for its substrate CO2 and has a slow enzymatic rate,
resulting in an inefficient metabolic pathway. By sequestering Rubisco in CBs along with additional co-factors,
cyanobacteria and many chemoautotrophs have enhanced carbon fixation. We propose studying shell assembly
and cargo organization in vivo and in vitro using cryogenic electron tomography (cryoET) and live cell imaging
using total internal reflection fluorescence microscopy (TIRFM) to understand internal and external factors that
affect BMC stability, permeability, and function. Understanding how this model BMC organizes during assembly
and throughout its life cycle will be critical for developing potential bioreactors with custom cargo for
pharmaceutical applications or increasing carbon fixation in photosynthetic organizations for improved crop
yields and decreasing atmospheric carbon.

Public health relevance
PROJECT NARRATIVE Bacterial Microcompartments (BMCs) are an increasingly relevant area of bacterial research with a spectrum of applications from antibiotic resistance to bioengineering custom bioreactors for pharmaceutical applications. This project seeks to answer how BMC shells are assembled and maintained, how cargo is organized, and how these areas of regulation change over the lifetime of the cell using the carboxysome as a model system. We propose using cryogenic electron tomography (cryoET) in vivo and in vitro as well as live cell imaging with fluorescent reports using total internal reflection fluorescence microscopy (TIRFM) to probe these questions.